Impact of Grin2b/GluN2B disruption on dopaminergic function and related behavior

PROJECT SUMMARY
The gene that encodes the NMDA-GluN2B subunit (GRIN2B) is one of the top 10 genes implicated by de novo,
gene-disrupting single nucleotide variants (SNVs) in autism spectrum disorder (ASD). Multiple mouse models of
ASD risk genes show abnormalities in the dopamine system, suggesting this as one potential point of
convergence. Some neuroimaging and clinical data also point to the dopamine system in ASD, including the use
of medications targeting the dopamine system and triggering of repetitive behaviors following dopamine agonists.
In prior work, we had found that increased or decreased expression of the neuronal glutamate transporter
EAAT3, which modulates NMDA-GluN2B receptor function, reciprocally impacts dopaminergic neuron firing,
striatal dopamine release, and resulting repetitive behavior. We now have evidence that pharmacological
inhibition of NMDA-GluN2B attenuates dopaminergic neuron firing and downstream behavior. Despite published
and preliminary data suggesting that NMDA receptors containing GluN2B play a critical role in modulating
dopaminergic neuron function, this has not been assessed using genetic mouse models of GluN2B disruption.
We therefore propose to use a conditional Cre/lox strategy to assess the impact of GluN2B loss in dopaminergic
neurons. We hypothesize that diminished signaling at NMDA-GluN2B receptors will decrease dopaminergic
neuron firing, resulting in diminished baseline and evoked dopamine release, and downstream alterations in
impulsive behavior and habitual learning. We will test this hypothesis by comparing mice with heterozygous loss
of GluN2B in dopaminergic neurons with littermate controls. Importantly, we will primarily focus on heterozygous
loss to parallel the human de novo variant findings; however, we will also study homozygous Grin2b conditional
knockout animals to better reveal the biological impact of GluN2B-containing NMDA receptors in dopaminergic
neurons, as well as the potential for developmental compensation. We will pursue our hypothesis using in vivo
extracellular single-unit recordings from optogenetically identified dopaminergic neurons, fiber photometry
monitoring of dopamine release in the striatum, and operant-based behavioral tasks assessing impulsive
responding and habitual learning. Our results will illuminate NMDA-GluN2B mechanisms of dopaminergic neuron
regulation, as well as the relationship with downstream behavior. They may also reveal opportunities for precision
medicine interventions, both for GRIN2B-related developmental disorders and for other subgroups with altered
dopaminergic function.

Public health relevance
PROJECT NARRATIVE Mutations in GRIN2B, which encodes the GluN2B subunit of NMDA receptors, confer risk of ASD, but the underlying mechanisms remain unclear. We found that increased or decreased expression of the neuronal glutamate transporter, which modulates NMDA-GluN2B function, reciprocally impacts dopaminergic neuron function – a key neurotransmitter system associated with ASD – and downstream behavior. Here, we propose to determine the impact of diminished NMDA-GluN2B expression in dopaminergic neurons on dopaminergic neuron firing, release, and resulting behavior, with the goal of elucidating impact of Grin2b in dopaminergic circuits, and potentially informing precision-medicine interventions with NMDA-GluN2B compounds.